Metal-free, genetically encoded reporters for calcium recording with MRI

Many leading questions in neuroscience such as how neurons encode experience, modify behavior, and
degenerate, require neural activity to be monitored throughout the brain in living animals. Neuronal activity is
tightly linked to an increase in intracellular calcium. Therefore, a cornerstone technology for monitoring neural
activity involves the use of genetically encoded fluorescent reporters of intracellular calcium. While fluorescent
tools for calcium sensing have proven immensely transformative for neuroscience research, optical approaches
do not allow neural activity to be monitored with brain-wide coverage or at any arbitrary depth. To address this
challenge, we will develop a new type of genetic sensor for visualizing cumulative calcium signals at a brain-
wide scale using magnetic resonance imaging (MRI). To construct these sensors, we will leverage water
channels known as aquaporins. We will build on our earlier discovery that aquaporins can be used to generate
diffusion-weighted MRI contrast by increasing the rate of water exchange across the cell membrane. Unlike
conventional MRI reporters, aquaporin-based contrast does not involve the use of metals, thereby permitting
fully autonomous, single-gene imaging with high sensitivity. To accomplish our goals, we propose two inter-
connected specific aims. In the first aim, we will develop aquaporin-based reporters of calcium signaling (ARCS)
by assembling a synthetic multi-gene cluster for coupling stimulus-evoked rises in intracellular calcium to
aquaporin expression. ARCS will permit neural activity to be integrated over defined stimulation epochs in awake,
freely behaving animals and subsequently read out by MRI. Following optimization in cell lines, we will validate
key performance attributes and safety profiles of ARCS in primary neurons. In the second aim, we will establish
in vivo functionality of ARCS by imaging local and brain-wide activation in response to well-established
neuromodulation paradigms involving chemogenetic and optogenetic inputs to the ventral tegmental area (VTA).
Concurrently, we will benchmark ARCS against multiple complementary readouts of neural activity including
blood oxygenation level dependent (BOLD) fMRI, calcium-sensing fluorescence reporters, and c-fos
immunohistochemistry. The anticipated outcome of this project is an optimized and well-validated set of genetic
tools that will provide neuroscientists with new avenues for unbiased exploration of neural networks involved in
coordinating everything from sensory function to behavior generation.

Public health relevance
The goal of this project is to develop a genetically encoded calcium integrator for noninvasive whole-brain mapping of neural activity in animal models, using magnetic resonance imaging (MRI). These tools will be derived from water channels known as aquaporins, optimizing using techniques drawn from mammalian synthetic biology and molecular engineering, characterized in model cell lines and neurons, and finally demonstrated in mouse models involving chemogenetic and optogenetic neuromodulation of the neural reward circuitry. By enabling noninvasive access to neural activity at a whole-brain scale and in a repeatable fashion, the proposed work will establish a transformative capability for basic neuroscience research.